Pilot Project Program

The proposed P30 Phase III Pilot Project Program will primarily act as a mechanism to fund pilot studies that
allow junior and senior investigators to generate preliminary data for submission of grant applications using the
unique technologies available in the cores. Through this program we expect to incentivize use of our core
technologies enabling all investigators but particularly past and present COBRE target faculty to gather
preliminary data to test and develop new hypotheses. As a result, we expect to greatly increase the
competitiveness of grant applications that when funded may also require future use of core resources. Since
the projects will vary widely in scope and needs, we have decided to create three different routes to fund pilot
applications. SC BioCRAFT TIGER CUB grant (up to $10K): These grants will be used to obtain data critical to
submission of a larger (R-type) grant. Investigators who have already submitted a grant application to external
agencies and are looking to revise their application with new data will be given priority for such an award. SC
BioCRAFT TIGER grant ($10k-50K): These grants will be reserved for High Risk- High Reward type
applications that propose groundbreaking research in the area of regenerative medicine. These can be single
PI or multiple PI proposals. SC BioCRAFT TIGER STREAK grant: ($50k-75K). The purpose of the TIGER
STREAK grants program is to provide financial support for the establishment or expansion of multidisciplinary
collaborations, which will lead to the development of more competitive, center-type proposals and significant
collaborative proposals. Total money available for pilot projects will be $200K/year. Vouchers are to be used to
cover the costs of services available through the cores. The annual budget for the voucher program will be
$40K /yr. with limitations to the number of vouchers per PI. The Administrative Core through its Program
Coordinator will have responsibility for implementing and managing this program. Program guidelines and
application instructions will be posted on the COBRE website and applications will be submitted to the Program
Coordinator using web-based forms. Applications will be solicited four times annually and will be advertised on
our website as well as locally and regionally by emails via statewide networks. Applications will be reviewed by
the Internal Advisory Committee. Criteria will include, 1) scientific merit, 2) alignment to the scientific themes of
our center, and 3) the perceived benefit (e.g. manuscripts, grants) to be derived from the expected data.

Public health relevance
The proposed P30 Phase III Pilot Project Program will primarily act as a mechanism to fund pilot studies that allow junior and senior investigators to generate preliminary data for submission of grant applications using the unique technologies available in the cores. Such program will allow researchers to perform regenerative medicine research which would improve public health if successful.